Effects of HIV, antiretroviral therapy, and PrEP on placental structure and metabolic function

PROJECT SUMMARY
Significance: Antiretroviral medications (ARVs) to treat and prevent HIV infection in reproductive-aged women
have been a landmark public health success, having averted millions of pediatric HIV infections. In addition to
taking ARVs as HIV treatment, pregnant women are increasingly taking ARVs as pre-exposure prophylaxis
(PrEP) against HIV infection. However, recent studies have shown that ARVs in pregnancy may also confer
risks to the developing placenta and fetus. Low placenta weight, placental insufficiency, and maternal vascular
malperfusion are more common among WHIV taking ARVs compared to WHIV not taking ARVs, and WHIV
initiating ARVs pre-conception have a 35% higher risk of having a small-for-gestational-age baby than WHIV
initiating ARVs post-conception. ARVs are life-saving HIV therapy and prevention, but PrEP safety in pregnant
women, their fetuses, and their offspring is unknown. Information about the safety of PrEP in pregnancy is
urgently needed to improve selection and management of ARVs as PrEP and HIV treatment during this high-
risk time. Innovation: We propose the first study to simultaneously compare placenta structure, angiogenesis,
and metabolic capacity between HIV-uninfected women taking ARVs as PrEP, WHIV taking ARVs, and HIV-
uninfected women taking no ARVs to determine the independent effects of ARVs and HIV on the placenta.
Distinct advantages of our proposed research include 1) simultaneous collection and comparison HIV-exposed
and -unexposed and ARV-exposed and -unexposed placentas, and 2) longitudinal observation of all children
over the first 12 months of life to relate placental findings to birth weight and infant growth. Investigators: Our
interdisciplinary team with expertise in placental pathology and HIV epidemiology (PI Bebell, an early career
NIAID K23-funded investigator), translational laboratory work on the placental effects of HIV and antiretrovirals
(Co-I Serghides), biostatistics (Co-I Rabideau) and maternal health (contributor Ngonzi), is well-poised to
complete this work. Approach: We will leverage stored placental and plasma samples from the PI's ongoing
NIH Career Development Award (K23AI138856) cohort in Uganda, clinical data from enrolled women and their
children, and Dr. Serghides' established laboratory infrastructure to elucidate the independent effects of HIV
and ARV exposure on the placenta and potential contribution of these changes to early child growth through
these specific aims: 1) Compare placental structure and angiogenesis by maternal ARV and HIV exposure
status. 2) Compare placental metabolic capacity by maternal ARV and HIV exposure status. 3) Determine the
effects of placental structure and metabolic capacity on birth weight and infant growth. Identifying mechanisms
of ARV-related placental toxicities has great potential to improve pregnancy outcomes through optimized PrEP
and ART regimens. Using data gathered we will submit an R01 proposal to investigate placental abnormalities
for specific ARV regimens to help determine the safest options for pregnant women.

Public health relevance
PROJECT NARRATIVE Antiretroviral medications (ARVs) to treat and prevent HIV in pregnant women have been a landmark public health success, having averted millions of pediatric HIV infections. However, recent studies have shown that ARVs in pregnancy may also confer risks to the developing placenta and fetus, and additional information about the effects of ARVs is urgently needed to improve ARV selection and management during this high-risk time. In this study, will use stored placental and plasma samples and clinical data from an ongoing birth cohort study to elucidate the independent effects of HIV and ARV exposure on the placenta and potential contribution of these changes to early child growth.